Cell intrinsic antiviral mechanisms targeting human enteroviruses

Project Summary
Enteroviruses A, B, C, D are important pathogens that can cause a range of diseases including myocarditis,
encephalitis, meningitis, conjunctivitis, hand, foot and mouth disease, and acute flaccid myelitis. Disease
outcomes can be severe or fatal, particularly in neonates and children. The host innate immune response
generally controls these viruses. However, the cell intrinsic antiviral mechanisms that mediate this host
defense are not well defined. Here, we propose to identify and characterize host antiviral genes encoding
both constitutively expressed (non-inducible) and interferon-stimulated gene (ISG) antiviral effectors. In
Aim1, we will examine TRIM7, a constitutively expressed E3 ligase that we recently showed inhibits
enterovirus replication by targeting a viral protein for degradation. We hypothesize that TRIM7 is a pan-
enterovirus restriction factor in vitro and in vivo. In Aim 2, we will leverage our expertise in ISG screening
technology to test the hypothesis that only a limited set of genes are true effectors of the interferon-induced
antiviral response to enteroviruses A-D. We will characterize antiviral effector mechanisms of action, and we
will use novel lipid nanoparticle gene delivery strategies to demonstrate antiviral efficacy in vivo. Both Aims
will be achieved by a combination of biochemical, virological, and genetic approaches in cell-based assays
and in mouse models of enterovirus infection and pathogenesis. Completion of the proposed aims will
provide fundamental knowledge about the specific molecules that confer cell intrinsic protection against
these enteroviruses. These studies may additionally inform the development of pan-enterovirus therapies
based on the mechanisms of these naturally occurring antiviral defense proteins.

Public health relevance
Project Narrative Enteroviruses in the Picornaviridae family have the potential to cause severe disease in humans, with notable outbreaks affecting children. This proposal seeks to define the genetically encoded host molecules that naturally defend cells from diverse human enteroviruses A, B, C, and D. Determining the mechanisms of these host defense proteins may uncover a pan- enterovirus “Achilles’ heel” that can be leveraged for the development of therapies broadly targeting this class of human pathogens.